The role of inflammation in driving leukemogenesis in germline predisposition syndromes

PROJECT SUMMARY
Germline predisposition to hematopoietic malignancies (HMs) is more common than previously appreciated, but
individuals are spread throughout the country, with few local experts. The NIH provides focused clinics for
patients with germline GATA2 mutations under Drs. Holland and Hickstein and for those with germline RUNX1
mutations under Dr. Liu. The proposed U01 consortium will engage four extramural investigators, Drs. Lucy
Godley (The University of Chicago), Anupriya Agarwal (Oregon Health & Science University), Emery Bresnick
(University of Wisconsin-Madison), and Nancy Speck (University of Pennsylvania) to perform complementary
studies using primary samples from patients seen at the NIH Clinical Center. Increased inflammation is
characteristic of the infections suffered by immunodeficient individuals with germline GATA2 mutations, and
preliminary data from the extramural investigators suggest that germline RUNX1-mutant cells produce increased
levels of inflammatory molecules. The U01 investigators hypothesize that inflammation derived from intrinsic and
extrinsic sources drives bone marrow failure (BMF) in GATA2-mutant patients, plus clonal hematopoiesis (CH)
that frequently evolves into HMs in both syndromes. The U01 consortium will test this hypothesis using three
Aims: Aim 1- Identify which germline GATA2 and RUNX1 VUSs are deleterious by analyzing their influences on
BM hematopoietic stem and progenitor cells (HSPCs) and mesenchymal stromal cells (MSCs). VUSs identified
in patients presenting to the NIH Clinical Center will be characterized functionally using growth and differentiation
assays of patient-derived HSPCs, non-hematopoietic MSCs, and an MSC cell line benchmarking them against
wild-type and known deleterious or benign variants. Aim 2- Establish how inflammatory mechanisms interface
with germline GATA2 and RUNX1 mutations to alter HSPC and MSC growth and differentiation. We will identify
the inflammatory cytokines/chemokines overproduced by RUNX1- and GATA2-mutant BM cells in response to
TLR4 ligands and determine their impact as well as that of LPS on colony formation, serial-replating, and
differentiation of RUNX1- and GATA2-mutant HSPCs and MSCs. We will establish a pre-clinical model of
inflammation-induced BMF in Gata2-deficient mice and determine the contribution of elevated TLR signaling to
their hematopoietic defects. Aim 3- Determine how acquired mutations and inflammation promote the expansion
of germline-mutant HSCs. CH occurs more frequently and at an earlier age in patients with germline GATA2-
and RUNX1-mutations compared to the general population. We will use xenograft and syngeneic mouse models
to determine how inflammation drives bone marrow failure in Gata2-deficient mice and facilitates the
growth/survival of germline GATA2- or RUNX1-mutant HSPCs with acquired somatic mutations, providing a
clonal advantage that ultimately evolves into leukemia. The results of these studies will be used to design a
clinical trial to decrease systemic inflammation and delay or prevent clonal expansion and risk of developing
BMF and HMs, thus improving the lives of our patients.

Public health relevance
PROJECT NARRATIVE The proposed U01 consortium will expand long-standing work centered at the NIH Clinical Center focused on individuals with germline GATA2- or RUNX1-mutations who are at high-risk for developing bone marrow failure (BMF) and hematopoietic malignancies (HMs). Intramural and four extramural investigators will test the hypothesis that inflammation derived from intrinsic and extrinsic sources drives BMF in GATA2-mutant patients, plus clonal hematopoiesis that frequently evolves into HMs in both syndromes. The results of the planned work will identify new biomarkers and pathways associated with BMF and HMs and lead to novel strategies to lower systemic inflammation and slow or prevent clonal expansion that could be tested in a clinical trial.